Renal sphingosine-1-phosphate receptor 1 in salt-sensitive hypertension

Sphingolipids were originally thought to serve as silent structural elements of the cell membrane. Recently,
sphingolipid metabolites are emerging as important lipid signaling molecules. Among them, sphingosine-1-
phosphate (S1P) is known to play important roles in cellular processes in various organ systems including the
cardiovascular system and kidney. Five members of the S1P receptor family (S1P1–S1P5) have been
identified. The S1P1-3 receptors are ubiquitously expressed, while S1P4 is in the lung and lymphoid system,
and S1P5 mainly in brain tissue. The S1P1-3 receptors are present in the kidneys. It has been shown that S1P
system plays a significant role in the pathogenesis of many diseases, including cardiovascular and kidney
diseases. Notably, the functions of three S1P receptors in the kidneys are different. S1P1 mediates protective
effects, whereas S1P2 and S1P3 mediate injurious effect in the kidneys. Despite many reports showing the
involvement of S1P pathway in renal physiology and pathology, little is known about the role of renal S1P
system in Na+ excretion. We have recently demonstrated that S1P1-3 receptors are prominently expressed in
the renal medulla, mainly located in the collecting ducts, and that S1P1 receptor in the renal medulla mediates
a strong natriuretic effect via inhibiting epithelial Na+ channel (ENaC). Our preliminary data showed that high
salt intake upregulated the level of S1P1 in the renal medulla, and interestingly, deoxycorticosterone acetate
(DOCA) treatment significantly reduced the level of S1P1 in the renal medulla. In mice with collecting duct
(CD)-specific S1P1 knockout (KO), the pressure natriuresis was blunted and high salt intake promoted more
Na+ retention compared with control mice. Furthermore, high salt intake produced a salt-sensitive hypertension
in CD-specific S1P1 KO mice but not in control mice when treated with a subpressor dose of DOCA. On the
other hand, infusion of BAF312, a selective S1P1 agonist, locally into the renal medulla remarkably attenuated
DOCA-salt hypertension. Based on these findings, we hypothesize that the renal medullary S1P1 pathway is a
critical counterbalancing mechanism to inhibit the excessive Na+ reabsorption and that suppression of renal
medullary S1P1 pathway contributes to the development of salt-sensitive hypertension. Three specific aims are
proposed to test our hypothesis. Aim 1: To determine whether the suppression of S1P1 pathway in the renal
medulla contributes to the pathogenesis of salt-sensitive hypertension. Mice with CD-specific deletion of S1P1
or CD-specific overexpression of S1P1 transgene will be used. Aim 2: To determine whether S1P1 pathway
inhibits ENaC activity and thereby increases Na+ excretion, exerting the antihypertensive action. Patch clamp
studies of ENaC channel activity in freshly isolated collecting ducts will be performed. Aim 3: To explore the
mechanism by which S1P1 activation inhibits ENaC activity to exert antihypertensive action via Gi
protein/cAMP-coupled signaling. The proposed studies will reveal a novel molecular mechanism in renal Na+
handling and provide new insights into the pathogenesis of salt-sensitive hypertension.

Public health relevance
Project Narrative: The high salt diet stimulates the expression of renal sphingosine-1-phosphate receptor 1 (S1P1), which increases the excretion of extra sodium load. Dysfunction of the S1P1 signaling pathway promotes sodium retention and causes high blood pressure. Clarification of this mechanism may ultimately suggest new therapies associated with enhancing S1P1 function for the treatment of high blood pressure.